Imaging Iron-Rich Pathology to Monitor and Diagnose FLTD Subtypes

PROJECT SUMMARY
Frontotemporal lobar degeneration (FTLD) is a debilitating neurodegenerative disease that in almost all cases
has one of two underlying proteinopathies – FTLD-tau and FTLD-TDP. To date MRI-based measures have not
been able to reliably distinguish clinical syndromes or their underlying proteinopathies. A key feature of FTLD
is the localized pattern of degeneration associated with various disease subtypes. These spatial patterns have
been associated with clinical syndromes, as well as the underlying proteinopathies that are most-relevant for
treatment studies. However, to date these patterns alone are not sufficiently specific to fully predict syndromes
or separate FTLD-tau from FTLD-TDP in a single patient. We have recently shown that, in addition to atrophy,
FTLD is associated with iron-rich cortical pathology. Moreover, our findings indicate that the specific cortical
layers impacted by this pathology are distinct in FTLD-tau and FTLD-TDP, offering a potential target for the
development of imaging biomarkers.
We propose to use iron-sensitive MRI as the basis for the development of novel imaging biomarkers, with the
aim of both monitoring disease progression and diagnosing underlying pathologic subtypes, addressing a
highest priority recommendation of the 2019 ADRD Summit. We propose a two-pronged approach to this goal:
First, we will use joint ex vivo MRI and histopathology in 50 human hemispheres, donated by patients with
FTLD and typical age-matched controls, to quantify the distributions of iron-rich pathology. In particular, we will
quantify both the laminar distribution and its relation to the patients’ underlying proteinopathies. In addition, we
will evaluate the distribution of disease across the cortex, and associate this with clinical information collected
during the patients’ lifetimes, including clinical syndrome and more fine-grained measures of symptoms.
Second, we will use in vivo MRI at 3T and 7T with 100 FTLD patients an typical volunteers to develop and
validate imaging protocols sensitive to the pathologic iron. At 3T, we will focus on quantifying the distribution of
iron across the cortex. We will correlate these cortical findings with MRI-based measures of atrophy, and
clinical measures including both symptoms and blood and CSF-based measures of degeneration and
pathology. At 7T, we will develop and validate focal laminar imaging methods, with the aim of recapitulating our
ex vivo findings in living patients and age-matched controls.
The overall goal of this study is to develop and validate novel, iron-sensitive imaging biomarkers for FTLD to
both monitor and diagnose underlying syndromes and pathologies. The ability to disciminate underlying
proteinopathies is a key need in treatment trials which focus on either FTLD-tau or FTLD-TDP. Moreover,
measuring the quantity and distribution of iron in the brain will also be valuable for monitoring disease
progression, both in treatment trials, and more generally for FTLD patients in clinical care.

Public health relevance
PROJECT NARRATIVE To date, there are no available in vivo methods to distinguish critical sub-types of frontotemporal lobar degeneration (FTLD) that may be amenable to treatment. We have recently described iron-rich cortical pathology in FTLD, showing distinct laminar distributions associated with underlying proteinopathies. We will develop novel, iron-sensitive MRI protocols to monitor and diagnose FTLD pathologies in vivo, supporting future treatment trials that target individual proteinopathies.